Biostatistics and Data Management Core F

CORE F: BIOSTATISTICS AND DATA MANAGEMENT CORE
ABSTRACT
The Biostatistics and Data Management Core (F) supports the mission of the Penn Mental Health AIDS Research
Center (PMHARC) by providing statistical methods and data management expertise in the design,
implementation, and analysis of clinical and basic research related to mental health and HIV. In line with the
overall Specific Aims, the Core will continue to assist Center pilot investigators and other researchers engaged
in research that aligns with the mission in the planning and execution of exploratory investigations, proposal
development, and guidance on quantitative and qualitative data collection, management, and analyses. Core F
will continue to be a resource to investigators whose work is focused on the development of innovative, integrated
treatments to optimize psychiatric, behavioral, and medical outcomes and to achieve a better understanding of
the biological, psychological, and behavioral mechanisms underlying these combined illnesses and interventions
to improve overall well-being. The overall mission of Core F is to encourage and facilitate high quality innovative,
interdisciplinary, and translational mental health and HIV research in the PMHARC. The Core promotes the use
of rigorous statistical and analytic methodologies and effective data management by working across the Core
boundaries. Another mission of Core F is to facilitate the use of the PMHARC Clinical and Laboratory/Biomarker
Data Repository compiled from completed projects that were (co)-sponsored by the Center.

Public health relevance
N/A